Dynamic Evaluation of Neural Mechanisms for Affective Touch: Pathways for Touch-induced Pleasantness and Pain Modulation

Project Summary/Abstract
The exact mechanisms by which light stroking and deep pressure – components of massage therapy – induce
pleasantness and pain modulation are not understood. Given the frequent use of massage therapy for relaxation
and pain relief, and the need for complementary tools for chronic pain, there is a critical need to study the
mechanisms of specific forms of affective touch. Our long-term goal is to elucidate the mechanisms by which
manual therapies induce pleasant relaxation and pain relief. Our overall objectives in this application are to (1)
Determine the extent to which A- and C-fibers contribute to affective effects of gentle stroking, 2) Determine the
extent to which A- and C-fibers contribute to affective effects of deep pressure, and 3) Determine the contribution
of C-fibers to neural mechanisms of touch-induced pleasantness and pain modulation. We will also (Exploratory)
use machine learning to identify individual contributions of C-tactile (CT) fibers to neural mechanisms of touch
pleasantness and pain modulation, and the association of interoceptive sensibility with CT effects. Our central
hypothesis is that A-fibers are necessary but not sufficient for the pleasantness of gentle stroking and
unnecessary for its pain reduction, but are necessary and sufficient for the pleasantness and pain reduction of
deep pressure. Further, we hypothesize that left anterior insula and anterior cingulate cortex activation will predict
CT contributions to modulation of pain by touch. We will conduct a two session within-subject study in healthy
adult volunteers to test the effects of A- and C-fiber blockade on the pleasantness and pain modulation induced
by slow stroking (N = 24) and deep pressure (N = 24). We will then test effects of A-fiber blockade on brain
mechanisms of pain modulation during fMRI, and relationships between CT contributions and touch
pleasantness, pain modulation, and interoceptive sensibility (N = 36). Effects of CT inputs on heart rate variability
will comprise a secondary outcome. Upon successful completion of the proposed research, we expect to have
identified the role of A- and C-fibers in the pathways and major effects of affective touch. This contribution is
expected to be significant because it will define the pathways for two major forms of affective touch and their
effects on pain, providing reliable information about non-invasive measures for pain control and potential targets
for noninvasive neuromodulation of pain. Further, this project is innovative because it explores a novel affective
touch pathway, applies a novel method to causally test afferent pathways for affective touch, and uses machine
learning to explore individual differences in the contributions of CTs to neural mechanisms for affective touch.
Our proposed project seeks to elucidate pathways for two major forms of affective touch commonly engaged by
massage. This research will have a positive impact by opening new horizons for mechanistic research on effects
of touch in health and disease, and may provide targets for neuromodulation in the treatment of pain.

Public health relevance
Project Narrative The proposed research is relevant to public health because the research findings will elucidate mechanisms for effects of slow stroking and deep pressure – components of massage therapy – on touch pleasantness and pain modulation. The proposed research will also characterize a novel pathway for affective deep pressure and elucidate its peripheral and central mechanisms, opening new horizons in mechanistic research on massage. The project is relevant to NCCIH’s mission because it addresses fundamental, real-time mechanistic processes of components of massage therapy.